Impact of Vpr-induced epigenetic remodeling on HIV persistence

IMPACT OF VPR-INDUCED EPIGENETIC REMODELING ON HIV PERSISTENCE
ABSTRACT:
HIV remains a significant problem worldwide, and despite advances in HIV therapies, a cure has yet to be
discovered. A major barrier to virus eradication is the establishment of long-lived cell reservoirs that harbor latent
provirus or that sustain chronic low-level virus production; therefore, achieving a cure will require a better
understanding of reservoir formation and HIV persistence in these cell populations. While extensive effort has
been directed at understanding reservoir formation in CD4+ T cells; much less is known regarding myeloid cell
reservoirs. Thus, detailed mechanistic studies of factors that regulate HIV persistence in myeloid cells may reveal
novel therapeutic targets that can be leveraged to eliminate this cell reservoir.
One such factor is the HIV accessory protein Vpr, which is essential for pathogenesis in vivo and virus
replication in myeloid cells, but not CD4+ T cells. However, Vpr’s primary function in myeloid cells remains
enigmatic. This proposal will test the hypothesis that Vpr facilitates HIV persistence in myeloid cells by inducing
epigenetic remodeling and chromatin opening at the integration site for sustained HIV transcription. Our
preliminary studies support this model and indicate that epigenetic remodeling requires Vpr-triggered DNA
damage repair signaling, which is a well-documented Vpr activity of unknown virologic function. The goals of this
proposal are to characterize how Vpr remodels the nuclear environment and define its role in HIV persistence in
macrophages through three specific aims, 1) characterize the functional impact of Vpr-directed epigenetic
remodeling on the HIV promoter during acute infection and latency reactivation, 2) delineate the mechanism(s)
of Vpr-induced epigenetic remodeling, and 3) comprehensively define Vpr-substrate interaction surfaces.
Detailed mechanistic insights that reveal how Vpr reprograms the cellular environment are critical for
understanding its role in HIV pathogenesis and have the potential to yield novel therapeutic targets that can be
leveraged to diminish HIV pathogenesis in vivo, contributing to the long-term NIAID goal of virus eradication.
1

Public health relevance
IMPACT OF VPR-INDUCED EPIGENETIC REMODELING ON HIV PERSISTENCE NARRATIVE: Although current therapeutics have proven successful in suppressing HIV disease progression, they fail to eradicate viral reservoirs; therefore, novel strategies are needed to cure HIV-infected patients. A major barrier to virus eradication is the establishment of long-lived reservoirs that harbor latent proviruses or sustain chronic low-level virus production. This proposal will explore the role of the HIV accessory protein Vpr in viral persistence in macrophages, which may uncover novel therapeutic targets that can be leveraged to contribute to the long-term NIAID goal of virus eradication. 1